Reconstitution and biophysical study of chromosome segregation machinery

PROJECT SUMMARY
An exquisite molecular machine, the mitotic spindle, separates duplicated chromosomes during cell division. To
uncover how it operates, we are reconstituting spindle activities using purified components and developing
biophysical tools to directly manipulate and track their dynamics at the single molecule level. The accuracy of
eukaryotic chromosome segregation is incredible and depends critically on kinetochores, which are multiprotein
complexes that maintain strong yet dynamic attachments between chromosomes and spindle microtubules in
order to produce force and move the chromosomes. Kinetochores also carry out vital regulatory activities such
as distinguishing and selectively stabilizing proper attachments, releasing erroneous attachments, and
generating diffusible ‘wait’ signals to delay mitosis until proper attachments are achieved. Our reconstitution-
based approach has enabled the first direct measurements of many fundamental kinetochore activities and direct
tests of long-standing hypotheses from cytological studies, proving for example that tension stabilizes
kinetochore attachments in at least two different ways. Our work has also revealed previously unrecognized
kinetochore behaviors and motivated new genetic, cytological, and structural studies. Our preliminary data now
reveal another striking and previously unrecognized behavior: yeast kinetochores grip the sides of microtubules
with directionally asymmetric strength – much more strongly when pulled toward plus ends than when pulled
toward minus ends. This asymmetric grip strength is likely to promote proper attachments in early mitosis when
kinetochores first bind the sides of microtubules. We will uncover its molecular basis, test its conservation in
human kinetochores, determine how it relates to the catch bond-like activity we previously uncovered and to the
widely studied kinase-based mechanism for correcting erroneous attachments, and ultimately develop a new
integrated explanation for the high fidelity of mitotic chromosome segregation.

Public health relevance
PROJECT NARRATIVE During cell division, duplicated chromosomes are organized and separated by an exquisite molecular machine called the mitotic spindle. To uncover how the spindle works, we are reconstituting its activities using isolated components and developing biophysical tools to directly manipulate and track their dynamics at the single- molecule level. Having a complete understanding of the spindle promises to revolutionize the development of new anti-cancer chemotherapeutics and ultimately may guide efforts to create human-designed molecular machines, which so far cannot match those found in nature.